Virus-Like Particle Based Immunization Against Peanut Allergy

Virus-Like Particle Based Immunization Against Peanut Allergy
PROJECT SUMMARY
Food allergies result from unbalanced immune responses that result in the production of IgE and the
aberrant activation of granulocytes and related cells in an IgE-dependent manner. Peanut allergy is the most
serious of these conditions, affecting more than 2% of children in the U.S. with potentially severe
consequences. The oral immunotherapy standard of care provides only temporary relief when effective, and
frequently gives rise to serious side effects. Its effectiveness is associated with the production of antigen-
specific IgG antibodies, suggesting that an immunization protocol which gives rise to a specific, high-affinity
memory response may comprise a direct and long-lasting therapy against food allergy. This program
combines the skills of a laboratory experienced in the design and production of immunogens based on protein
nanoparticles with leading investigators in the study and treatment of food allergy. The research will explore
a subunit vaccine strategy in which allergenic and non-allergenic peptides derived from two important peanut
allergens, Ara h 2 and Ara h 6, are presented on the surface of immunogenic virus-like particles in a well-
controlled and well-characterized manner. The response to these candidate vaccines will be compared to
formulations incorporating the full-length proteins, and the best candidates will be advanced to tests of allergy
inhibition in two mouse models. The first is a standard model of allergy and anaphylaxis induced by
administration of the allergen and cholera toxin as an adjuvant, and the second is a new mouse strain that
exhibits a more clinically relevant phenotype in which allergy is induced by oral consumption of the allergen
without adjuvant. If the immune response is indeed able to be focused on specific allergenic sequences, one
would be able to determine if a minimized set of IgG responses can induce significant protection and to
develop effective combinations that achieve the desired goal with a minimum of side effects.

Public health relevance
Virus-Like Particle Based Immunization Against Peanut Allergy PROJECT NARRATIVE Peanut allergy is the most serious of food allergies, with potentially severe consequences for a large and growing number of children; while effective long-lasting therapies do not exist, positive short-term effects of treatment result when one branch of the immune system is induced to react to peanut-derived molecules, thereby inhibiting the pathways that give rise to harmful allergic reactions. A new method is proposed to induce long-lasting immune responses of this helpful type. By the end of the two-year study, it will be known whether or not this approach is worth further development for clinical testing in humans.